MICROSCALE SAMPLE PREPARATION FOR MASS SPECTROMETRY

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. As new staff members join the laboratory, or present staff move on to new projects that require these skills, established group members provide group instruction and individual guidance so that the less experienced staff members can expedite their projects and gain expertise that will prove useful when they complete their postdoctoral or visiting positions and move on to more permanent employment. Training takes place on an individual basis or in a workshop format. Plans to conduct regular workshops continue. Training emphasizes sample recovery and a basic introduction into how samples should be analyzed. Collaborators are also included, as appropriate to their needs and interests.